IL-27 in skin host defense and regeneration

PPROJECT SUMMARY The skin forms an essential barrier that protects us from the environment. The goals of this study are to determine the contribution of skin immune cells and their products in wound repair and innate immune defense against invading and/or transmitted microbes, including Zika virus. This work will contribute significantly to the development of novel approaches for treating skin wounds and infections. .

Public health relevance
PROJECT NARRATIVE Human skin is a barrier organ and comprises an active immune system to provide host defense against otherwise deadly infections. This application will determine how IL-27 contributes to innate immune defense responses against virus infections, including Zika virus (ZIKV). ZIKV is transmitted primarily via the bite of a mosquito vector, which creates a wound in the skin. Our lab recently found that IL-27 is produced following cutaneous injury and initiates antiviral immune responses. In this application we plan to delineate IL-27's role in wound repair and the innate immune defense against virus infection.